Enhancing Participation of Historically Minoritized Groups in Alzheimer Disease and Related Dementias Research

Project Summary/Abstract
The national Conference, entitled “Enhancing Participation of Historically Minoritized Groups in Alzheimer
Disease and Related Dementias Research”, proposed in this application represents the intentional (but COVID
pandemic-delayed) follow-up to the 2018 national Workshop, “African American Participation in Alzheimer
Research: Effective Strategies”, held at Washington University (WU) in St. Louis on October 10th, 2018. The
Workshop was funded by R13 AG059415 (JC Morris, PI) and was hosted by WU’s Knight Alzheimer Disease
Research Center (ADRC). The audience for the 2018 Workshop included representatives from national (e.g.,
the National Institute on Aging, the Alzheimer’s Association, and the AfricanAmericansAgainstAlzheimer’s
Network) and St. Louis community (e.g., the African American Advisory Board for the Knight ADRC, the St.
Louis Clergy Coalition, and the St. Louis Chapter of the Links, Inc.) organizations that are committed to
improving diversity in research efforts to understand, reliably diagnose, and effectively treat Alzheimer Disease
and Related Dementias (ADRD). However, the primary audience was the leadership of each of the NIA-
funded ADRCs as the ADRC network supports the clinical cohorts that are recruited, enrolled, assessed, and
longitudinally followed to provide the data and biospecimens that are essential for scientific studies in ADRD.
The proposed Conference will be held at Washington University in St. Louis on October 12-13, 2023, to
address the continuing lack in the ADRCs of coordinated strategies to ensure the appropriate recruitment,
engagement, and retention of research participants from historically minoritized populations. There are four
Conference objectives: 1) to have the ADRC network adopt uniform definitions, terms, and language for use for
minoritized populations in ADRD research; 2) to review new batteries that obtain data on the social
determinants of health that contribute to racial and ethnic differences in ADRD; 3) to encourage the ADRC
network to address community-initiated research topics; and 4) to have the ADRC network incorporate a
uniform framework to enhance the recruitment, engagement, and retention of persons from minoritized groups
in ADRD research. To date, the proposed Conference has acceptances from 6 Moderators (2 women; 3
Black, 1 Asian; 1 Hispanic/Latinx) and 22 speakers (15 women; 8 Black, 3 Asian, 1 American Indian/Alaska
Native; 2 Hispanic/Latino/x/a). The effective strategies developed by the Conference will be used by the
ADRC network but also disseminated to the scientific community at large.

Public health relevance
Project Narrative There has been an enormous missed opportunity to fully understand the heterogeneity of Alzheimer disease and related dementias (ADRD) because the groups of research volunteers studied by Alzheimer Disease Research Centers (ADRCs) and related programs notably lack adequate numbers of individuals from historically minoritized groups. Together with many national and local supporters, the Knight Alzheimer Disease Research Center in St. Louis, Missouri will host a Conference to enable all 37 ADRCs to develop and implement effective strategies to improve diversity in recruitment, engagement, and retention in ADRD research. The Conference will expressly encourage engagement by community members to ensure that their priorities are addressed with culturally sensitive research approaches.